Mechanisms Driving Apoptosis Resistance in Pulmonary Hypertension

PROJECT SUMMARY
Pulmonary arterial hypertension (PAH) remains a fatal diagnosis despite available therapies. PAH is
characterized by extensive remodeling of the pulmonary vasculature involving the formation of vaso-occlusive
lesions and a thickened medial layer of the vascular wall, both of which contain pulmonary arterial smooth muscle
cells (PASMCs). It has been demonstrated that PASMCs isolated from a well-established rat model of PAH are
resistant to apoptosis under both basal and stimulated conditions. The cell membrane protein aquaporin 1
(AQP1) was initially described as a water transport channel, but more recently has been implicated in other
cellular functions including migration and proliferation, and in several distinct cancer types, has been associated
with apoptosis resistance. AQP1 is upregulated in PASMCs isolated from rat models of PAH suggesting a ‘quasi-
malignant’ disease model, although AQP1’s exact role in apoptosis resistance is unclear. Exciting new data from
an unpublished proteomics study using lung lysates demonstrates that AQP1 immunoprecipitates with total
caspase-3, a enzymatic protein activated in apoptosis which is translocated to the nucleus where it initiates cell
death. In proximity studies utilizing biotin ligase techniques, I have demonstrated that AQP1 and total caspase-
3 come within close proximity in live cells. Furthermore, in silico analysis of the AQP1 protein reveals 3 potential
caspase-3 cleavage sites, which provide a mechanism for this protein-protein interaction. Together, these data
suggest that AQP1 interacts with caspase-3, providing a novel relationship between AQP1, the caspase
cascade, and resistance to apoptosis. This application serves to provide a training vehicle as I explore a potential
mechanism by which AQP1 regulates apoptosis during PAH. Aim 1 is designed to determine whether the
cytosolic caspase-3 cleavage site(s) on AQP1 are necessary for AQP1/caspase-3 interaction, Aim 2 serves to
evaluate the impact of AQP1 on nuclear localization of capsase-3, and finally Aim 3 will establish if increased
AQP1 is necessary and/or sufficient to confer apoptosis resistance. Techniques utilized to address these aims
include but are not limited to protein expression and site directed mutagenesis, biotin ligase proximity assays,
co-immunoprecipitation, animal models of PAH and primary cell isolation, immunofluorescence and confocal
microscopy, nuclear/cytosolic fractionation, luminescent caspase-3/7 activity assay, Hoechst staining and
TUNEL staining. Completion of this project will provide novel insight into the interaction between AQP1 and
caspase-3 and the role for AQP1 in apoptosis resistance as well as provide a novel pathway for new therapeutic
targets. The skills obtained in the design and execution of this study and the experimental results will provide
the necessary foundation for a K award and an excellent platform on which to start a career as an independently
funded clinician scientist focused on PAH. Insights gained from this work also could have implications beyond
PAH to any diagnosis in which cellular resistance to apoptosis is essential to the development of disease.

Public health relevance
PROJECT NARRATIVE Pulmonary arterial hypertension (PAH) is a highly morbid disease that leads to right ventricular failure and mortality. Pulmonary artery smooth muscle cells in pre-clinical models of disease have been shown to resist programmed cell death, a critical step in the development and maintenance of PAH. I will study the role of the proteins aquaporin 1 and caspase-3 in promoting smooth muscle cell resistance to death.